Small Molecule Therapeutic for Heart Failure

Abstract
Heart failure is a major cause for global mortality/morbidity characterized by the loss of cell surface beta-
adrenergic receptor (βAR) which are powerful regulators of cardiac function. Epinephrine/norepinephrine
activates βARs leading to cAMP generation and cardiac contraction. Activated βARs are phosphorylated by G-
protein coupled receptor kinases resulting in β-arrestin binding and desensitization. Phosphorylated βARs
undergo endocytosis, and are dephosphorylated (ie resensitized) in the endosomes by protein phosphatase 2A
(PP2A) before being recycled back to the plasma membrane as agonist ready naïve βARs. This reflects a
dynamic regulation of βAR function by desensitization (phosphorylation) and resensitization (dephosphorylation).
Despite this dynamic regulation, desensitization is well understood, while less is known about resensitization in
in heart failure. Our seminal studies identified that phosphoinositide 3-kinase γ (PI3Kγ) phosphorylates an
endogenous inhibitor of PP2A (I2PPA) which robustly binds and inhibits PP2A activity thereby, impairing βAR
resensitization. In vivo studies using mouse models targeting I2PP2A showed that preservation of resensitization
results in maintenance of βAR function conferring cardiac protection. Consistently, βAR resensitization is
inhibited in end-stage human heart failure which is characterized by significant loss in PP2A activity compared
to non-failing hearts. These findings lay the rationale for the scientific premise that therapeutic approaches
to unlock the inhibition of PP2A activity leading to preservation of βAR resensitization would ameliorate cardiac
dysfunction. We came across a small molecule (TGI1002, TGI) in cancer space that maintains PP2A function
by targeting I2PP2A unlocking PP2A inhibition. As mechanistic basis for I2PP2A targeting by TGI is not known,
in silico docking, cellular and in vitro studies were performed which showed that TGI impaired I2PP2A binding to
PP2A resulting in sustained βAR-associated PP2A activity and preserved βAR resensitization. However, TGI
generates baseline cAMP, which is thought to be cardiotoxic. In recognition, our initial structure-design activity
studies led to analog like CCF002, which though not optimal has reduced baseline cAMP, improved in vitro
activity over TGI and importantly, mitigated cardiac dysfunction post-heart failure administration. Thus, the R61
phase is focused on understanding the pharmacophore to generate molecules that have minimal baseline
cAMP, higher in vitro efficacies through optimizing modifications on CCF002. This could lead to identification of
1-3 candidates with drug-like properties with higher efficacies and bioavailability preserving βAR resensitization.
The R33 phase is designed to comprehensively assess in vitro toxicity, off-target effects and efficacy on a
second hypertension-based model of heart failure in acknowledgement of the heart failure etiology. The studies
outlined in the grant application would allow us to translate early stage discovery to identify and characterize
potential therapeutic molecules for heart failure congruent with the Catalyze funding opportunity announcement
(FOA).

Public health relevance
Project Narrative A hall mark feature of heart failure (HF) is the consistent loss of beta-adrenergic receptor (βAR) function which is responsible for increasing cardiac contraction. There are no drugs that reverses or normalizes the loss of βAR function, as current treatment options only delay the progression of heart failure. Our studies have identified small molecules that restores βAR function and could be suitable for drug development studies to therapeutically target a novel pathway in heart failure.